Elucidating Systemic Inflammation in Hidradenitis Suppurativa using Single Cell Omics and Machine Learning

Project Summary
Hidradenitis suppurativa (HS) is an underrecognized common, immune-mediated skin disease characterized
by inflammatory nodules, abscesses, and sinus tracts in the groin, buttocks, and axillae leading to devasting
physical and emotional morbidity. Patients with HS display systemic inflammation with increased risk of co-
morbidities such as cardiometabolic disease. In this application, we use single cell technology and novel
bioinformatic and machine learning methods to identify dysregulated pathways in the circulating immune
system of HS patients. This study will advance our knowledge of the immunobiology of HS and identify new
biologic pathways that can be therapeutically targeted.

Public health relevance
Project Narrative Hidradenitis suppurativa (HS) is a debilitating, inflammatory skin disease with few effective therapies. There is a lack of biomarkers in HS. In this diversity supplement proposal, we use single cell technology and novel bioinformatics methods to identify dysregulated pathways and potential systemic immune biomarkers in HS.